Zebrafish Habitat Expansion

Abstract
UMaine’s Zebrafish Facility is critical to the success of most NIH funded faculty at UMaine. Overall, 12 UMaine
faculty, their technicians, undergraduate, and graduate students use the Zebrafish Facility for their research on
an annual basis. These faculty represent a number of different units at UMaine including the Department of
Molecular and Biomedical Sciences, the School of Biology and Ecology, and the School of Marine Sciences.
Zebrafish have been used by UMaine faculty studying many different disease processes, including influenza,
muscular dystrophy, and Candida fungal infections. The Zebrafish Facility is also relevant to UMaine faculty in
disciplines such as electrical and computer engineering, who are developing devices and technologies to
address the prevention and treatment of human disease processes.
UMaine’s current zebrafish facility typically operates at 98-100% capacity. Although an excellent facility that is
93% base-funded by the University of Maine; the limited capacity hinders all investigators who use the
zebrafish model. UMaine’s first Center of Biomedical Research Excellence (COBRE) grant, which started in
April 2023, provides the initial nucleus of funding for converting a teaching laboratory into an additional
zebrafish facility that will more than double the available space for zebrafish. The remainder of the necessary
funding for the renovation is being provided by the University of Maine, demonstrating the deep commitment of
UMaine to this project. The Office of the Vice President for Research at UMaine has also committed funds to
purchase some necessary equipment including the live feed systems, dosing system, spawning tanks, and
crossing shelves (see letter of support). Here, we propose to purchase the central filtration system for the
facility, as well as 11 double-sided racks and the AquaTouch 2 monitoring system. These will more than double
our current capacity for stock maintenance and increase daily breeding capacity from 25 to 175 tanks per day.
This increased capacity is necessary for the continued success of this shared zebrafish facility. Thus, receipt of
this grant will have a tremendous impact on research growth at the University of Maine.

Public health relevance
NARRATIVE: ZEBRAFISH FACILITY EXPANSION UMaine’s Shared Zebrafish Facility is critical for 12 faculty throughout the University of Maine. We propose to expand UMaine’s Zebrafish Facility to accomplish the following: increase nursery space to facilitate rapid growth of new lines, increase spawning space to increase experimental pace, and more than double the capacity of our current system.